BLRD Research Career Scientist Award Application

Dr. Vemuganti’s current research is to find therapies for preventing secondary brain damage and to promote
neurological recovery following either traumatic brain injury (TBI) or ischemic stroke. TBI and stroke are leading
causes of disability in service personnel and Veterans and they suffer the effects of these for decades after the
initial events.
Oxidative stress and endoplasmic reticulum (ER) stress that starts within hours and continues for days promotes
neuronal death that lead to long-term neurological deficits after TBI. Hence, the currently funded Merit Review
Grant of Dr. Vemuganti will test the hypothesis that an antioxidant combination therapy (to prevent the formation
of ROS and induce the disposal of ROS) protects the brain and promotes long-term functional gains in both
sexes at different ages after TBI. We further test the hypothesis that preventing oxidative stress and ER stress
together is more efficacious to protect the brain and to promote neurological recovery after TBI. We will also test
the hypothesis that controlling oxidative stress decreases the propensity of Parkinson’s disease (PD) pathology
after TBI. The studies will use a well-developed mouse model of TBI known as controlled cortical impact injury.
Motor function, cognitive function and neuropsychiatric function will be studied as well as cortical contusion in
mice subjected to TBI and treated with the combo therapies. Overall, the present project will help us to find a
drug combo that minimizes secondary brain damage and neurologic dysfunction after TBI by curtailing oxidative
stress and ER stress after TBI. The long-term goal is to provide a therapy to help service personnel and Veterans
who suffer a TBI.
Stroke promotes significant motor, cognitive and neuropsychiatric dysfunction. However, there is no efficacious
therapy to prevent post-stroke brain damage and neurologic deficits. Recent studies showed that modulating
specific microRNAs (miRNAs) leads to neuroprotection and better functional recovery after stroke in rodents.
The miRNA miR-21 is anti-apoptotic and anti-inflammatory. We observed that miR-21 levels in the brain
increases by treatment with a miR-21 mimic without any toxicity. Hence, in a Merit Review Grant that is currently
pending, Dr. Vemuganti will test the hypothesis that miR-21 mimic is a potent neuroprotective therapy to prevent
post-stroke brain damage using a mouse stroke model called transient middle cerebral artery occlusion (MCAO).
Stroke Treatment Academic Industry Roundtable (STAIR) stipulated many criteria for testing new therapies.
Following those, we will test the window of therapeutic efficacy, long-term motor, cognitive and neuropsychiatric
outcomes, effect of sex, age and diabetes (comorbid condition for stroke) on miR-21 mimic-induced
neuroprotection following transient MCAO. Recent studies showed that gut microbiome influences inflammation
in the post-stroke brain. Hence, we will further test the hypothesis that miR-21 mediated post-stroke
neuroprotection is due to prevention of gut microbiome dysbiosis leading to curtailed inflammation. The overall
goal is to establish miR-21 as a neuroprotective miRNA with potential to decrease post-stroke brain damage and
improve functional recovery by rectifying gut dysbiosis and inflammation. If successful, these studies leads to
establishment of miR-21 as a new therapy to help service personnel and Veterans who suffer a stroke.

Public health relevance
TBI is a major health problem in Veterans of all ages. The negative impact of this devastating condition on Veterans will increase enormously unless new therapies that can minimize the secondary brain damage after TBI are tested and propagated to clinical trials. Oxidative stress and endoplasmic reticulum (ER) stress are controllable pathologic events that promoter neuronal death after TBI. In a current Merit Review Grant, the Vemuganti Lab is testing the long-term effects of a combo therapy that curtails oxidative stress and ER stress in rodents subjected to TBI. Stroke is also a major health problem of Veterans. Dr. Vemuganti’s pending Merit Review Grant will test the functional significance of a small RNA called miR-21 in protecting post-stroke brain and providing better functional outcome. We will further test if miR-21 prevents stroke-induced gut dysbiosis and the resulting inflammation, which might be a mechanism of its neuroprotective efficacy.